Impact of structural racism on hospital/clinic closures, community assets, and health outcomes in urban communities

Project Summary/Abstract
Structural racism, defined as the ways in which societies foster discrimination through mutually
reinforcing inequitable systems, has emerged as an important social risk factor and contributor to poor health
outcomes for racial/ethnic minorities (Egede 2020, Bailey 2017). Structural racism captures upstream historic
racist events (such as slavery, black code laws, Jim Crow laws, and school segregation) and more recent state
sanctioned racist laws in the form of redlining. Redlining refers to the practice of systematically denying various
services to residents of specific neighborhoods/communities, often based on race/ethnicity (Bailey 2020).
A first important link between historic redlining and health outcomes is likely related to health care
access in the form of accessible hospital and neighborhood clinics, as well as the quality of these facilities. A
second important linkage between historic redlining and health outcomes is likely associated with the way in
which structural racism (in the form of redlining) has systematically deprived neighborhoods of economic
opportunities, and as such, of the ability to build individual and community assets in the form of housing value,
employment, and educational opportunities for its residents. These linkages between structural racism, access,
community assets, and health disparities, are furthermore of significant current policy relevance as recent
trends indicate a growing number of hospital and clinic closures due to the COVID-19 pandemic (Ellison 2021).
However, the link between historic redlining and urban hospital and clinic closures as well as
community assets and community health outcomes are poorly understood. The goal of this project is to inform
our understanding of the pathways between structural racism (defined as historic redlining), urban hospital and
clinic closures, community assets, and health outcomes; and to further inform policies that can help reduce the
impact of structural racism on health disparities caused by hospital and clinic closures. The present study
seeks to accomplish this objective by using recently developed causal and interpretable machine learning
methods, along with econometric counterfactual analysis, to address the following aims: 1) Examine the
relationship between regional exposure to structural racism and the propensity of hospital and clinic closures.
2) Examine the relationship between hospital and clinic closures and community employment, income, and
education, as well as community health outcomes. 3) Predict risk of closure among urban hospitals and clinics
that are disproportionately serving racial/ethnic minorities from neighborhoods with exposure to structural
racism. 4) Undertake stakeholder engagement to address prevention of future closures and/or examine ways
to decrease the potential adverse community impact of hospital and clinic closures. The study is innovative in
its examination of the linkages between structural racism and health outcomes; its emphasis on identifying
policy channels for reducing the perpetual impact of structural racism; and its methodological use of a broad
set of mixed methods to achieve these aims.

Public health relevance
Project Narrative This study seeks to use novel methods and data to address the following aims: 1) Examine the relationship between regional exposure to structural racism and the propensity of hospital and clinic closures; 2) examine the relationship between hospital and clinic closures and community assets (pertaining to employment, income, and education) and community health outcomes (across mortality, disability, and chronic disease burden); 3) predict risk of closure among urban hospitals and clinics that are disproportionately serving racial/ethnic minorities from neighborhoods with exposure to structural racism (defined as historic redlining); 4) undertake stakeholder engagement to address prevention of future closures and/or examine ways to decrease the potential adverse community impact of hospital and clinic closures.